Penn Alzheimer's Disease Research Center (ADRC)

Penn ADRC Overall Project Summary
The mission of the University of Pennsylvania’s Alzheimer’s Disease Research Center (Penn ADRC) is to
increase research and education on Alzheimer’s disease (AD) and its links to related dementias (ADRD) with
the goal of identifying the causes of and cures for AD/ADRD. To do so, the Penn ADRC will address one of the
fundamental barriers to effective treatment or prevention, which is the significant phenotypic, pathological, and
sociodemographic heterogeneity of AD. We will embrace and seek to characterize and understand this
heterogeneity to ultimately achieve a precision medicine approach leading to targeted interventions that will
facilitate realization of the National Alzheimer’s Project Act’s (NAPA) ambitious goal of effective prevention or
treatment by 2025. Indeed, the Penn ADRC is constructed to directly contribute to a number of the milestones
of NAPA necessary to achieve this goal.
Emerging from the 30-year history of the Penn Alzheimer’s Disease Core Center (ADCC), the Penn ADRC
benefits from a rich scientific milieu in which there is significant integration and collaboration across Penn’s
neurodegenerative disease centers. This construction is critical to the understanding of AD heterogeneity
which is driven, in part, by overlapping pathologies and mechanisms, such that cross-degenerative disease
studies are of increasing importance in capturing the full spectrum of disease. This environment has led to a
history of transformative research that has influenced understanding of disease definition and mechanisms,
diagnostic approaches and biomarker development, statistical and bioinformatics methodology, and ethical,
social and legal perspectives of those suffering from this condition and their care partners. It has also created
an intellectual, cultural, and physical setting dedicated to training the next generation of investigators and
clinicians, as well as partnering and educating the community.
To achieve our mission, the Penn ADRC will bring together eight cores (Administrative; Biomarker; Clinical;
Data Management and Statistical; Genomics; Neuroimaging; Neuropathology; Outreach, Recruitment, and
Engagement) and the Research Education Component (REC). These highly integrated cores will support
development of a phenotypically, pathologically, and ethno-racially diverse cohort which will be deeply
characterized through cognitive assessments, measures of social determinants of health, genetics, biofluid and
neuroimaging biomarkers, and autopsy. All these data will be stored within the Integrated Neurodegenerative
Disease Database (INDD), which is linked to the other neurodegenerative centers at Penn and will contribute
to our understanding of the upstream factors and processes that lead to AD heterogeneity and its downstream
manifestations. Further, the ADRC supports robust sharing of these data and participation in larger NIA and
national programs. The REC leverages these cores and their research programs for training new investigators.
Together, the Penn ADRC will advance our ultimate mission to reduce the tremendous burden of AD.

Public health relevance
Penn ADRC Project Narrative The Penn ADRC is highly aligned with and will contribute to the National Alzheimer’s Project Act’s (NAPA) ambitious goal of effective prevention or treatment of Alzheimer’s Disease and Related Dementias (AD/ADRD) by 2025. To achieve this goal, the Penn ADRC will provide intellectual and physical infrastructure to support research and education across the continuum of normal aging to dementia with the goal of identifying the causes of and cures for AD/ADRD, with a particular focus on AD heterogeneity. The Center will contribute to transformative local efforts, but also will actively participate in broader national efforts, including many supported by the National Institute on Aging.